T and B Cell Collaboration in Germinal Centers and Beyond

ABSTRACT
Support is requested for a Keystone Symposia conference entitled T and B Cell Collaboration in Germinal
Centers and Beyond, organized by Drs. Shane Crotty, Michela Locci and Jennifer Gommerman. The conference
will be held in Whistler, British Columbia, Canada from October 1-4, 2023.
T cell/B cell interactions are fundamental for numerous immune responses. And, as the COVID-19 pandemic
demonstrated, the successful development of COVID-19 vaccines highlighted the extreme value of T and B cell
interactions for protective immunity. For example, the development of antibodies able to neutralize variants as
diverse as Omicron, after not one or two but after three other mRNA immunizations, with the same ancestral
SARS-CoV-2 Spike, is a dramatic example of the importance of germinal centers in protective immunity, and the
brilliance of the immune system in rapidly evolving T-dependent B cell responses capable of neutralizing extreme
viral variants the cells never previously encountered in the germinal centers. However, there remains much to
be learned about the critical importance of T cell/B cell interactions and germinal centers for vaccines and
infectious diseases. Furthermore, the relevance of these immunological interactions is much broader in
biomedicine. T cell/B cell interactions are important in many autoimmune diseases. Moreover, this conference
will be held jointly with the Keystone Symposium on B Cells and Tertiary Lymphoid Structures: Emerging Targets
in Cancer Therapeutics and there will be joint sessions covering T cell/B cell interactions in cancer.

Public health relevance
PROJECT NARRATIVE T cell/B cell interactions are fundamental for many immune responses and the field only continues to advance, especially as highlighted with the COVID-19 pandemic with the development of multiple vaccines to combat the infection. This conference will gather the leading experts in the field to discuss the most recent research and cutting-edge technological advances in the field. This conference will also provide attendees with an interactive venue to foster discussion of discoveries and research priorities to advance the study of T cell/B cell interactions in health and disease.